Respiratory Drive in Acute Respiratory Failure

PROJECT SUMMARY/ABSTRACT
Acute respiratory failure (ARF) requiring invasive ventilation occurs in one-third of intensive care unit (ICU)
patients and is associated with a high risk of death. Ventilation-induced lung injury (VILI) is a modifiable
determinant of ARF outcomes that develops when the at-risk lung experiences excessive global or regional
stress/strain. VILI may result from excessive forces applied by the ventilator and/or respiratory muscles.
Optimizing ventilator titration has been studied extensively, while far less is known about the contribution of
spontaneous breathing effort to VILI in ARF. High respiratory drive can cause injuriously high tidal volumes,
increasing global stress/strain either with synchronous effort or breath stacking dyssynchrony depending on
ventilator mode. High drive also causes temporally heterogeneous insufflation, increasing intra-tidal regional
strain for a given tidal volume. Both patterns of respiratory drive-related increase in stress/strain worsen lung
injury in preclinical models and have been observed in patients with ARF, but whether they contribute clinically
meaningful lung injury in patients is unclear. Extremes of drive, high or low, also may cause clinically relevant
diaphragm injury. High drive risks load-induced injury, particularly in flow-limited ventilator modes or certain
patient-ventilator dyssynchronies in which inspiratory support ends prematurely relative to patient effort. Low
drive risks diaphragm disuse atrophy, proven to occur in some patients within a few days on the ventilator.
Causes of drive heterogeneity in ARF are not well established. Chemoreceptor, mechanoreceptor, and cortical
inputs (e.g. pain, anxiety) are well established modulators of respiratory drive, but they alone do not fully
explain drive heterogeneity in ARF. Although deep sedation often suppresses respiratory drive in healthy
individuals, we recently found that sedation depth and respiratory drive are not well correlated in ARF. Many
patients exhibit high drive refractory to deep sedation, while in others even light sedation can completely
eliminate drive. Our preliminary data suggest differences in systemic inflammation might explain this drive
heterogeneity. This research will deepen understanding of mechanisms underlying drive heterogeneity and its
relationship with clinical outcomes in patients with ARF. Our overall hypothesis is that systemic inflammation is
a key determinant of respiratory drive, extremes of which cause clinically important lung and diaphragm injury.
We will assemble a prospective two-hospital, multi-ICU cohort in whom respiratory mechanics and serum
biomarkers are ascertained serially. Aim 1 evaluates circulating inflammatory markers as a potential contributor
to drive heterogeneity. Aim 2 determines mechanisms by which extremes of respiratory drive may contribute to
lung and diaphragm injury. Aim 3 evaluates the relationship between respiratory drive and time to extubation.
Findings from this work will inform development of a precision ventilation strategy, incorporating respiratory
drive to optimize lung and diaphragm protection, for evaluation in a future clinical trial.

Public health relevance
PROJECT NARRATIVE Acute respiratory failure requiring mechanical ventilation is a common cause of morbidity and mortality during critical illness. Spontaneous drive to breathe varies in unpredictable ways during acute respiratory failure and could be protective or harmful depending on clinical context. This research will deepen understanding of mechanisms underlying respiratory drive heterogeneity and its relationship with clinical outcomes in mechanically ventilated patients with acute respiratory failure.